Advanced Training in Nursing Outcomes Research

This is a continuation application for years 26 through 30 of the Advanced Training in Nursing Outcomes
Research (T32NR007104) pre- and post-doctoral training program, funded by NINR. Over its lifetime, our T32
program has trained 32 PhDs and 43 postdoctoral trainees who are now doing research in more than 40
different institutions across 23 states. 95% of alumni are at research-intensive institutions, and 86% obtained
research funding after completing their training. We seek funding to continue providing advanced training in
nursing outcomes research for 5 predoctoral and 3 postdoctoral trainees each year. Our aim is to prepare a
diverse cohort of independent nurse investigators equipped with the advanced methods, data science tools,
and conceptual grounding necessary to untangle the multiple ways in which policies, systems, and models of
nursing care intersect and drive health inequities across settings and populations. We also aim to increase the
pipeline to PhD study by recruiting underrepresented undergraduates into research careers through expedited,
tested, and well-supported 3-year BSN to PhD educational pathways. Housed in the Center for Health
Outcomes and Policy Research (CHOPR) at Penn Nursing, the Outcomes Research T32 offers a vibrant,
collaborative, and interdisciplinary team-science environment with unparalleled resources and learning
opportunities including: 1) close mentorship from leading nurse scientists; 2) access to troves of unique data
that can be used to study a wide array of populations, clinical settings, and policy challenges; 3) a large
interdisciplinary T32 faculty with a deep reservoir of funded research and expertise; 4) collaborative cross-
campus research centers and a world-class health system eager to partner and use evidence to transform
practice; and 5) a scholarly community committed to solving big, complex problems with rigorous, collaborative
science. Trainees learn through multiple modalities including: 1) a rich university curriculum and curated
concentration courses for PhD students; 2) enrichment and supplementary support to ensure all postdocs have
the skills they need to jump right into their scholarship; 3) embedded real-world research experiences with
experts; 4) small group and one-on-one support from data science and statistician staff; 4) multiple
opportunities for hands-on application of data science skills; 5) stimulating T32 and cross-campus seminars
with leaders in health policy and research; 6) engaging training in the responsible conduct of research and
reproducibility; and 7) professional development and networking support to ensure smooth transitions to the
next career stage. The nurse scientists completing our program will be prepared to employ rigorous state-of-
the-art, multi-level and intersectional research approaches to root out the policies, systems, and models of care
that do not work equitably. Likewise, they will be prepared to implement new policies, systems, and models of
care to ensure optimal health for all. The focus on policy, systems, and care models; health equity and social
determinants; and data science align with NINR and NIH Priority Areas for Training.

Public health relevance
Project Narrative This proposal is for continuation of the highly successful Advanced Training in Nursing Outcomes Research program at Penn Nursing. We aim to develop a diverse cohort of expert nurse scientists equipped with the advanced methods and data science approaches needed to conduct rigorous research that improves patient outcomes and health equity in all the places nurses work with patients.